Regulation of Hematopoiesis by the EZH2-PRC2 Complex

Project Abstract
EZH2 is the catalytic subunit of the PRC2 (Polycomb repressor complex 2) that mediates the
trimethylation of histone H3 lysine 27 (H3K27me3), a critical histone modification associated with
gene silencing during cell fate specification and development. Overexpression or activating
mutations in EZH2 are associated with various types of human cancers, including blood cancer.
But the mechanisms by which the overexpressed or overactivated EZH2 causes various cancers
or promotes their progression remains largely unclear. We have recently found that EZH2 is
lysine-methylated and such methylation regulates EZH2 protein stability. EZH2 therefore joins to
a group of proteins that include DNA (cytosine-5)-methyltransferase 1 (DNMT1), SOX2, and
HIF1α which undergo methylation-regulated and ubiquitin-dependent proteolysis. Our group has
identified a methyl lysine reader, L3MBTL3, that recognizes the methylated K20 in EZH2 to
promote its proteolysis by the CRL4DCAF5 ubiquitin ligase complex. Using the CRISPR-Cas9 gene
editing, we have generated a mouse knock-in mutant strain that converts the K20 codon to
arginine (K20R) in Ezh2 to produce the Ezh2K20R mutant protein that is resistant to the
methylation-dependent proteolysis. We found that the homozygous Ezh2K20R mice produced an
expansion of hematopoietic stem/progenitor cell (HSPC) compartments in bone marrow with
hepatosplenomegaly. With the Ezh2K20R mutant mice as a model, we hope to test the hypothesis
that a gain-of-function mutant of Ezh2 may alter the balance of self-renewal and differentiation of
stem cells/progenitor cells, a mechanism potentially linked to an overactivated EZH2 in promoting
cancer development. We propose to characterize the Ezh2K20R knock-in mice to determine if the
Ezh2K20R mutant protein affects the expansion or differentiation, or both, of the hematopoietic
progenitor cells and to identify novel partners for Ezh2 during these processes. Our Specific Aim
1 is to characterize if a specific stage in the erythroid lineage progression is affected by the
Ezh2K20R mutation. Our Specific Aim 2 is to investigate if Gfi-1b, a protein that is strongly induced
by the Ezh2K20R protein in a hematopoietic organ, is a component of Ezh2-PRC2 complex. Our
Specific Aim 3 is to use CRISPR-Cas9-mediated gene editing to generate S21A and K20R/S21A
knockin mutations. As our earlier studies showing that S21-phosphorylation and K20-methylation
are mutually exclusive, we would predict that S21A mutation being a hypomorphic mutation while
the K20R/S21A double mutation being a stronger gain-of-function mutation than K20R alone.
Through these studies, we hope to understand how Ezh2 orchestrate a developmental program
of self-renewal and differentiation to regulate stem/progenitor cell during hematopoiesis.

Public health relevance
Project Narrative EZH2 catalyzes tri-methylation on histone (H3K27) to mediate gene silencing. Overexpression or gain-of- function mutations of EZH2 are frequently found in human cancers. We propose to use a novel mouse model to study how EZH2 regulates stem cells on the balance between self-renewal and differentiation process.